Dissecting Neuro-Immune Interactions in Cancer

PROJECT SUMMARY/ABSTRACT: Cancer is highly adept at exploiting normal physiological functions to
support its growth. One important component of tissue physiology is neurons which weave through our
organs, releasing neuropeptides into nearby tissue. Importantly, the role innervation plays in malignancy and
anti-tumor immunity remains largely unknown and understudied. Our preliminary analysis shows that tumor
infiltrating immune cells express high levels of receptors for sensory neuropeptides, which further positively
correlates with expression of genes associated with immune cell dysfunction. These data suggest that
innervation may play an important role in regulating anti-tumor immunity. To test this hypothesis, we propose
strategies to investigate the role of innervation in cancer, and to determine how neuropeptide sensing on
immune cells impacts anti-tumor immunity in the following objectives:
Objectives of Unnerving Cancer: (1) Investigate the degree of sensory neuron innervation in cancer (2)
Determine how neuropeptide sensing on DCs impacts anti- tumor immune responses.
Using reporter tools and multiplexed imaging, we will determine innervation of tumor tissues in pre-clinical
models and patient samples. Building on our results, we will investigate the functional and transcriptional
effects of neuropeptide sensing on immune populations using endogenous and syngeneic models.
Results from this project have the potential to significantly advance our current understanding of the nervous
system's contribution to cancer. Therapeutically, exploiting the neuronal vulnerability of cancer using existing
clinically approved neuromodulators has the potential to rapidly translate clinically for the prevention and
treatment of cancer. The legacy of this NCI funded interdisciplinary research will be to understand the neuro-
immune communication in cancer, opening doors for novel therapeutic strategies.
Keywords: Tumor Immunology, Immunotherapy, Cancer Neuroscience, Dendritic cells, Neuro-Immune
Interactions
Graphical Abstract: Tumor innervation correlates with poor survival in several tumours. I propose to study
neuronal density in Skin and Lung tumour, and query correlation of neuronal density to therapeutic responses.
I hypothesise that Sensory Neurons release neuropeptides, including CGRP, which acts on receptor
expressing dendritic cells (DCs). Together this leads to blunted DC responses perpetuating CD8+ T cell
dysfunction and tumor progression.
Objective 1
Objective 2

Public health relevance
PROJECT NARRATIVE: It is expected that novel pathways and neuro-immune mechanisms uncovered by this research will have far reaching consequences in terms of how neurons regulate immune responses in inflammation and cancer, thus enhancing our understanding of the immune system in health and disease.